Community Outreach & Engagement

COMMUNITY OUTREACH AND ENGAGEMENT (COE) – PROJECT SUMMARY/ABSTRACT
The overarching goal of UVA Cancer Center (UVACC) Community Outreach and Engagement (COE) is to
reduce the burden of cancer across the cancer continuum. COE follows a systematic process of strategic
planning and evaluation to identify needs in the catchment area and, with UVACC leadership, prioritize
programs and engagement strategies to address these needs through outreach and research. COE is led by
Wendy Cohn, PhD, Associate Director for COE and is supported by the Office of Community Outreach and
Engagement (OCOE) and the Community Advisory Council (CAC). A deep understanding of the catchment
area through needs assessments and collaborations with the diverse communities, organizations, and health
systems provide a strong foundation. COE provides targeted, culturally-adapted, evidence-informed cancer
prevention and control strategies and facilitates research among investigators from all of the research
Programs in the UVACC. COE proposes to improve health equity across the cancer control continuum in the
catchment area and beyond by 1) identifying and describing the cancer burden and cancer risk in the
catchment area, 2) fostering collaborative, bi-directional research to address catchment area needs, and 3)
implementing and disseminating evidence-based interventions to the catchment and broader population.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.